Targeting Acid Ceramidase and Bcl-2 in Acute Myeloid Leukemia

PROJECT SUMMARY/ABSTRACT
Acute myeloid leukemia (AML) is a heterogeneous disease characterized by uncontrolled proliferation of myeloid
blasts resulting in bone marrow failure. The median age at diagnosis is 68 and the 5-year survival rate for
individuals over 60 is 13%. Thus, there is an urgent unmet need for improved therapeutics for AML. Sphingolipids
are an important class of amphipathic lipids that regulate proliferation, drug resistance, and apoptosis. The
balance of pro-apoptotic ceramides and pro-survival sphingosine-1-phosphate (S1P) constitutes the bioactive
core of sphingolipid signaling. Acid ceramidase (AC) is a lipid hydrolase that catabolizes ceramides and
generates the critical substrate for S1P synthesis, sphingosine. We previously demonstrated that AML blasts
rely on AC for survival. Transcriptomic analyses and AC activity assays showed AC gene expression and activity
upregulated in primary AML samples. Genetic knockdown of AC with shRNA reduced cell viability and
downregulated the pro-survival protein, Mcl-1, in human AML cell lines and patient samples. Pharmacological
inhibition of AC with the ceramide analog, SACLAC, resulted in caspase-dependent apoptosis in multiple human
AML cell lines and primary AML patient samples. Mass spectrometric sphingolipidomic profiling of SACLAC
treated AML cell lines showed a reduction of S1P and a widespread increase in ceramide levels. Intriguingly,
SACLAC treatment led to alternative splicing of Mcl-1 to its shorter pro-apoptotic isoform, Mcl-1S, and the ratio
of Mcl-1S to full-length Mcl-1 determined cell survival. Importantly, full-length Mcl-1 overexpression or Mcl-1S
knockdown attenuated SACLAC toxicity in AML. Venetoclax (ABT-199), a highly selective inhibitor of pro-survival
Bcl-2, is approved for relapsed AML and is being tested in several clinical trials. However, responses to ABT-
199 as a single agent are short-lived and resistance develops through the upregulation of Mcl-1, a Bcl-2 homolog.
Here, we propose dual targeting of AC and Bcl-2 in AML. Our central hypothesis is that targeting AC will
synergize with ABT-199 and overcome ABT-199 resistance in AML. Since genetic and pharmacological inhibition
of AC modulates Mcl-1, we hypothesize that targeting AC will synergize with ABT-199 to overcome ABT-199
resistance in AML through an Mcl-1-mediated mechanism (Aim 1). Because sphingolipid dysregulations are
involved in cancer progression and drug resistance, we will characterize whether AML with acquired resistance
to ABT-199 share a specific sphingolipid profile and whether certain sphingolipid species contribute to ABT-199
resistance (Aim 2). Overall, these experiments aim to identify a novel therapeutic approach for AML that
combines AC inhibition and Bcl-2 family inhibitors in order to provide the rationale for further preclinical studies
targeting AC and Bcl-2 family proteins in AML.

Public health relevance
PROJECT NARRATIVE Acute myeloid leukemia (AML) remains an incurable disease with a standard of care that has changed little over the last four decades. As a result, there is an unmet need for new and improved therapies for AML. We propose that targeting sphingolipid metabolism, bioactive lipids that control cell survival and apoptosis, in conjunction with Bcl-2 family apoptosis regulators will provide therapeutic and synergistic benefits in AML.